DEXAMETHASONE THERAPY IN INFANTS AT HIGH RISK FOR CHRONIC LUNG DISEASE

Dexamethasone therapy will be tested for the shortening of the duration of intubation and mechanical ventilation for VLBW infants who are at risk for chronic lung disease in a multicenter, randomized, placebo- controlled, masked, clinical trial. (NICHD Neonatal Research Network)